Expanding the set of genetically encoded tools for compartment-specific manipulation of redox metabolism in living cells

Abstract
One of the most important organizing principles in all life forms is the uninterrupted flow of electrons through
reactions that involve reduction-oxidation (redox) changes. Not surprisingly, an imbalance in this fundamental
cellular process, i.e. redox homeostasis, has been attributed to numerous diseases, including mitochondrial
disorders, cancer, diabetes, neurodegeneration and the aging process itself. The redox cofactors, NADH and
NADPH, and their oxidized forms are key contributors to the cellular redox environment, but it is unclear whether
perturbations in their metabolism contribute directly to disease etiology or is simply a reflection of ongoing
pathology. For most of these conditions, it is not known whether the observed redox imbalance is linked to
altered bioenergetic efficiency or to a cellular process that is neither linked to ATP production nor to
maintenance of the mitochondrial membrane potential. Another major challenge is that some of these redox
reactions are redundant, i.e. have overlapping substrate dependency (towards NAD(P)H) or are found in
more than one cellular compartment. To systematically address these pressing questions, methodology to
modulate the steady-state concentrations of the NADH and NADPH cofactors is needed. Recently, we have
developed genetically encoded tools to selectively decrease the NADH/NAD+ and NADPH/NADP+ ratios in
live cells that are based on the heterologous expression of native or engineered versions of bacterial H 2O-
forming NAD(P)H oxidases. In this proposal, we plan to expand our toolkit by developing a genetically
encoded tool for the direct modulation of NADH reductive stress (i.e. increased NADH/NAD+ ratio) (Project
1). Preliminary screening of several bacterial enzymes has furnished promising candidates for driving NADH
overproduction in different cellular compartments. The development of compartment-specific tools will enable
studies to elucidate how overproduction of reducing equivalents in one cellular compartment is communicated
to another and how NADH reductive stress remodels cellular metabolism (Project 2a). Multiple lines of
evidence indicate that NAD(P)H-consuming redox cycling agents at low concentrations mildly exhaust
antioxidant systems and that the resulting pro-oxidative shift promotes stress resistance and improves heathspan
in several model organisms. We are using Drosophila as a model organism, to directly test whether redox
modulation in either the oxidative or reductive direction are correlated with stress resistance, healthspan and
lifespan (Project 2b). A third goal is to develop variants of our genetically encoded tools that are controlled by
small molecules or by light to afford greater spatiotemporal control (Project 3). The latter is especially
important as many redox processes crucial for redox signaling or energy metabolism and dysregulated in
pathologies, occur rapidly (on an acute time scale). The successful completion of our studies will lead to
enabling technologies for modulating the redox environment, which will be widely useful for metabolic studies on
an acute or chronic time scale at the resolution of subcellular compartments.

Public health relevance
Narrative We propose to develop novel methodologies to enable modulation of the cellular redox environment with spatiotemporal precision. The methodology will be based on native or engineered enzymes that will be amendable to targeting to different cellular compartments. Our tools will lead to a better understanding of the role of redox imbalance in disease processes and hold therapeutic promise for reversing metabolic imbalances.